Function and Regulation of Airway Mucin Glycosylation

PROJECT SUMMARY
The lungs are exposed to billions of potentially harmful particles daily. Robust defense is crucial, but protection
must cause minimal physiologic disruption. Accordingly, a thin and easily transported layer of mucus lines the
airways in health. In asthma, mucus aggregates on airway surfaces and obstructs airflow, but this is not
effectively treated with existing therapies. We seek to close this gap by building a better mechanistic
understanding of how mucus function and dysfunction are mediated by the chief macromolecules in airway
mucus--MUC5AC and MUC5B. Their importance is well-recognized through studies in humans and animal
models. MUC5B is required for mucociliary clearance, host defense, and survival in both species. Muc5ac is
dispensable in healthy mice, but in human asthma and in mouse models, it causes airway obstruction. Both
mucins also have host defense and pathogenic roles in non-respiratory tissues. Accordingly, despite clear
significance, there is a need to find treatments that prevent mucus dysfunction while also preserving defense.
To investigate this, we are focusing on the defining characteristic of mucins – heavy O-glycosylation – and how
MUC5AC and MUC5B glycosylation is carried out in the Golgi apparatus. Mucin glycosylation terminates
when sugars such as fucose (Fuc) are attached. This terminal fucosylation process in mucins is mediated by
the enzyme fucosyltransferase 2 (FUT2), which catalyzes transfer of Fuc to galactose (Gal) acceptors forming
Fuc(α1-2)Gal bonds. FUT2 absence is protective in people with asthma and in mouse models where its
deficiency protects against mucus plugging and obstruction. Fucosylation increases mucus viscoelasticity,
transport, and aggregation, and it is associated with excessive mucus viscoelasticity, and asthma severity.
Accordingly, a mechanistic understanding of how FUT2 mediates mucin fucosylation will reveal novel
strategies that could be used to target mucus dysfunction in asthma. We hypothesize that trans Golgi-
localized FUT2-dependent mucin fucosylation mediates allergic airway mucus dysfunction. We will test this in
three Specific Aims that 1) test the hypothesis that mucin α1,2-fucosylation requires FUT2 localization and
activity within trans Golgi compartments; 2) test the hypothesis that conserved catalytic sites and non-catalytic
regions in FUT2 are required for mucin α1,2-fucosylation; and 3) test the hypothesis that Golgi specific FUT2-
dependent α1,2-fucosylation mechanisms mediate mucociliary dysfunction and mucus obstruction. Our
focused investigations could reveal ways to target the important, but currently untreatable, problem of mucus
hypersecretion while also helping resolve unanswered basic science questions.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Asthma is a common disease that has major impacts on human health, health care costs, and economic well- being. Airway passages are lined by a protective mucus barrier that becomes detrimental in asthma, resulting in impaired mucociliary clearance and disrupted breathing. Our research focuses on how specific proteins – MUC5AC and MUC5B – are produced and how they affect the functions of airway mucus in health and disease.